The Impact of ATR Kinase Inhibitors on CD8+ T Cell Expansion and Memory Development

PARENT GRANT – ABSTRACT (as per original submission)
The overarching goal of our laboratory is to determine how DNA damage response inhibitors (DDRi) can be used
to potentiate cancer cell killing while concurrently increasing anti-tumor immune responses after radiation therapy
(XRT). The DNA Damage Response (DDR) is a signaling system that integrates DNA repair pathways and the
cell cycle to safeguard genome stability. In addition to activating cell cycle checkpoints and DNA repair in cells
treated with XRT, the DDR limits origin firing and delays cell cycle transitions in unstressed cells. While cyclin-
dependent kinases are cell cycle accelerators, DDR kinases are cell cycle brakes and, in this analogy, DDRi
disable the brakes, causing unchecked acceleration. Here we will determine how the DDR is rewired in CD8+ T
cells to accommodate massive and concomitant DNA replication and transcription in S phase. We will also
determine the impact of DDRi in cancer and immune cells. We hypothesize that ATR kinase inhibitors induce
origin firing that causes ribonucleosides to be mis-incorporated into the genome, and that this generates
chimeric RNA-DNA fragments and type I IFN-dependent immunologic memory after XRT. To test our
hypothesis in cancer and immune cells, we have generated an innovative transplantable model of cancer. The
Mcm4Chaos3/Chaos3 mouse carries a mutation in Mcm4 that destabilizes the replicative helicase. Cells derived
from Mcm4Chaos3/Chaos3 mice have a 60% reduction in origin licensing. We have generated
Mcm4Chaos3/Chaos3 B16 cancer cells that can be transplanted into Mcm4wt/wt and Mcm4Chaos3/Chaos3
mice. This will allow us to separate the function of ATR that limits origin firing from that which mediates the repair
of replication forks in cancer and immune cells. In Aim 1, we will define cell cycle kinetics and determine how
ATR inhibitors induce DNA damage in immune and cancer cells in vitro. In Aim 2, we will define cell cycle kinetics
and determine whether ATR inhibitors induce DNA damage in immune cells and type 1 interferons in vivo. In Aim
3, we will determine whether ATR inhibitors combine with XRT to generate durable responses and immunologic
memory through effects on immune and/or cancer cells. Successful completion of this project will define how the
DDR is rewired in CD8+ T cells to accelerate cell cycle transitions and accommodate massive and concomitant
DNA replication and transcription in S phase which, accounts for ~70% of the cell cycle as G1 is abridged. These
studies are highly significant as the objective of checkpoint blockade and adoptive T cell transfer is to induce
rapid division in CD8+ T cells. Successful completion of this project will identify combinations and sequences of
DDRi that potentiate cancer cell killing while concurrently increasing anti-tumor immune responses in mouse
models of cancer treated with XRT. These studies are highly significant as we use DDRi that are currently in 115
clinical trials and XRT which is used to treat >50% of cancer patients, >60% with curative intent.
R01 Diversity Supplement
The goals of the current proposed research plan integrate with Aim 3 of the parent R01. The goal of the diversity
supplement is to determine the role of ATR signaling in T cell memory development. Previous findings in knockout
mouse models suggest that upstream and downstream signaling, by ETAA1 and DCK respectively, of ATR is
necessary for memory development. In addition, previous laboratory findings have shown that use of ATRi will
radiotherapy modulates the immunologic memory. Short-term ATRi treatments were found to potentiate memory
responses, while long-term use of this drug blunted immune memory development when combined with
radiotherapy. We hypothesize that ETAA1-dependent, ATR phosphorylation of DCK is essential for T cell
memory development and that ATRi can be used to potentiate memory. We will complete three aims in
order to determine this. Aim 1 will Determine whether ETAA1-ATR signaling is an intrinsic regulator of T cell
activation that impacts the development of T cell memory. Aim 2 will Determine whether DCK is an intrinsic
regulator of T cell activation that impacts the development of T cell memory. Aim 3 will Determine whether ETAA1-
ATR-DCK signaling is necessary for immunological memory responses to occur upon rechallenge. Successful
completion of these Aims will determine whether ETAA1-ATR-DCK activity in CD8+ T cells promotes memory
and whether this signaling axis can be targeted with pharmacologics to mitigate autoimmune diseases and
potentiate immune responses to infection and cancer. Successful completion of this proposal will directly prove
whether ATRi can potentiate the acquisition of immunologic memory and identify the optimal schedule of ATRi +
IR for clinical trials.

Public health relevance
Cancer is treated with DNA damaging chemotherapy and radiation therapy (XRT). Cancer cells are sensitive to DNA damage as they divide rapidly and have often acquired mutations in mechanisms that safeguard genome stability. Immune cells are also sensitive to DNA damage as they divide extremely rapidly (<6 h). Since cancer is treated with combinations of DNA damaging chemotherapy, XRT and immunotherapy, we investigate new approaches to separate the impact of DNA damage on cancer and anti-tumor immune cells.